CORE--BIOSTATISTICS

Core B will provide Biostatistical support to all projects. Personnel of the Core will work closely with members of Core E to coordinate the flow of data, will work with the investigators of each project to design appropriate analyses, and will perform those analyses. There with be three classes of related analyses: 1.) continued evaluation of data already collected by the current Program Project, 2.) analyses of new data that do not involve genetic variables, and 3.) genetic analyses. Although all of these analyses are important for the completion of the proposed research, the latter are the primary focus of the current application.